SR CA++ ATPASE TRANSGENE OVEREXPRESSION IN FAILING HEART

Heart failure is an abnormality of myocardial cell function resulting in impaired ventricular performance. The functional defect is unknown, but may be related to alterations in calcium (ca++) handling. Evidence suggests that the altered functional properties of the sarcoplasmic reticulum (SR) are in part related to a defect in the SR Ca++ ATPase pump as shown by the decreased expression of mRNA encoding the SR Ca++ ATPase gene in failing hearts. Recently transgenic technology has emerged as a valuable tool to study tissue specific and inducible gene expression in vivo. The goal of this project is to produce transgenic mice which overexpress cardiac SR Ca++ ATPase and apply it to a murine model of cardiac failure induced by pulmonary artery banding (PAB) that I have developed, to determine if SR Ca++ ATPase overexpression in heart failure can rescue the cardiac dysfunction. The present study proposes the following specific aims: 1) To characterize the in vivo murine model of compensated and decompensated heart failure produced by PA banding with respect to; a) The heart failure phenotype; hemodynamics, organ weights, and in vivo contractile function by digital contrast ventriculography. b) Genetic markers (expression of SR Ca++ ATPase, ANF, MLC-2 mRNA. 2) To produce transgenic mice using a MLC-2/SR Ca++ ATPase construct to overexpress SR Ca++ ATPase selectively in the ventricle. 3) To determine if overexpression of SR Ca++ ATPase can diminish the functional abnormality in failing hearts, the PAB model will be applied to transgenic mice which harbor the MLC-2\SR Ca++ ATPase transgene and characterized as in specific aim 1. 4) To assess myocardial calcium homeostasis in compensated and decompensated heart failure; Calcium transients in isolated papillary muscle from ventricles of normal and failing hearts which overexpress SR Ca++ ATPase will be determined.